MAINTENANCE OF THE NCI DRUG INFORMATION SYSTEM

The objective of this contract effort is to maintain and enhance the NCI Drug Information System (DIS). The DIS provides computer support essential for the everyday operations of the Developmental Therapeutics Program (DTP). The DIS manages every step a test compound takes from acquisition to shipment to the biological screens. The maintenance will include enhancing the software to perform additional functions, correction of errors, and the performance of operational tasks required for database correctness.